The role of geometric structure in avoidance of oxygen rebound to enable aliphatic halogenation and oxacyclization by non-heme Fe(IV)-oxo (ferryl) complexes

Abstract of Parent Award: (R01 GM141284 “The role of geometric structure in avoidance of oxygen rebound
to enable aliphatic halogenation and oxacyclization by non-heme Fe(IV)-oxo (ferryl) complexes”)
Iron(II)- and 2-(oxo)glutarate-dependent (Fe/2OG) oxygenases catalyze hydroxylation, halogenation, cyclization,
dehydrogenation, and stereoinversion of aliphatic carbon centers, C–H-bond-activation reactions that collectively
represent a holy grail of synthetic chemistry. Biosynthetic pathways to important natural-product drugs are
replete with these enzymes, and the pharmaceutical industry is beginning to leverage evolved versions of
Fe/2OG oxygenases as biocatalysts for "green" processes to their synthetic drugs. Recent studies of Fe/2OG
hydroxylases, halogenases and cyclases by the Penn State group show that the disposition of the substrate
relative to the common iron(IV)-oxo (ferryl) and iron(III)-hydroxo/substrate-radical intermediates may be crucial
for control of reaction outcome. On the basis of data available so far, we hypothesize that the structural
rearrangement of the metallocofactor rather than the substrate positioning is the primary factor directing
regioselectivity. Therefore, in this work, we will perform spectroscopic characterization of faithful reactive-state
analogs to gain first-hand insight as to how the individual enzymes adjust the structure of the active complex and
to uncover common modes that direct reactivities in the superfamily of Fe/2OG oxygenases. In this project, we
will innovate and deploy a suite of novel intermediate mimics and spectroscopic probes/methodologies to resolve
the geometries of the key intermediate states in the pharmaceutically relevant subclasses of Fe/2OG enzymes.
Our elucidation of how the cofactor structures and relative dispositions of the substrates dictate the divergent
outcomes will inform efforts to discover novel members of this superfamily and assign their phenotypes.
Ultimately, information obtained in this project will be instrumental in developing new biocatalysts for drug
synthesis.

Public health relevance
Project Narrative Non-heme-iron and 2-oxo-glutarate-dependent enzymes perform an incredible array of oxidative transformations in biosynthetic pathways of medicinal natural products. The parent project (R01 GM141284) seeks to understand which structural factors allow the metallocofactor in these enzymes to perform various reactions. This supplement requests a purchase of a cryogenic system that will allow to perform continuous wave EPR measurements at high frequencies.